Development of Coccidioides Cytokine Release Assay

Coccidioidomycosis (CM) is an endemic mycosis caused by the fungi Coccidioides immitis and
Coccidioides posadasii, which is native to arid regions of North and South America. It is
estimated that up to 350,000 infections occur annually in the U.S. Additionally, up to a third of
community acquired pneumonia cases in these areas are thought to be a result of CM.
Morbidity associated with CM is substantial with a median illness duration of 120 days. The
costs associated with CM are high, with an estimated annual direct healthcare cost of nearly
$200 million.
Currently, the diagnosis of CM is primarily based on detection of anti-Coccidioides antibodies.
Once infection clears, the antibody eventually becomes undetectable making it difficult to
determine if there was previous exposure. Classically, delayed-type hypersensitivity reactions
using skin tests have been used to evaluate the cellular immune response, which is indicative of
past infection. The commercially available Coccidioides skin test has suboptimal performance
characteristics and is not utilized often in clinical care.
The use of an ex vivo cytokine release assay (CRA) avoids the limitations associated with skin
testing while allowing for the detection of cytokines produced by stimulation with a pathogen-
specific antigen. Analogous to the commercially available CRA for tuberculosis, a Coccidioides
CRA would be a major advance for patient care and for evaluation of CM prevalence within
geographical regions and populations. Our data suggests a CRA for CM will be valuable as a
tool to detect patients with acute CM and stratify those with latent CM (those at risk for
reactivation if immunosuppressed). Climate change and incidence modelling predict endemicity
to expand from 12 to 18 states and incidence to increase by 50%, stressing the need for a
public health screening tool to establish changing boundaries and stratification for high risk
occupations and future vaccine trials.,
The goal of this application is to develop a CRA to assist in the diagnosis, management, and
epidemiology of CM, which increasingly afflicts people living in or travelling through areas where
it is endemic. This phase II grant will seek to establish and define the prototype assay for clinical
use.

Public health relevance
Narrative. Coccidioidomycosis is a significant source of morbidity, mortality and cost within endemic regions. Disease presentation can range from asymptomatic to life threatening disseminated disease in immunocompromised individuals. It is also estimated that between 15%- 30% of community acquired pneumonia is attributable to coccidioidomycosis within endemic regions. Those on immunosuppressive therapies, such as those receiving organ transplants, are at risk for severe Coccidioides infections. The development of an ex vivo cytokine release assay has several potential benefits to aid in the diagnosis, management and distribution of coccidioidomycosis. It could be used to test for previous infection in populations or in individuals. This use could help establish prevalence in geographic areas and determining the measures to take before beginning immunosuppressive therapy. The test could also have prognostic value, as development of a lasting cellular immune response has been associated with positive outcomes. The presence or absence of an adaptive cellular immune response and the ability to reliably monitor it will be critical to the development and monitoring of individuals that will receive a future coccidioidomycosis vaccine.